DEVELOPMENT OF SECRETORY VESICLES IN GLANDS OF CANNABIS

Developmental sequences of secretory vesicles at surface of disk cell wall in noncellular secretory cavity of gland will be examined by TEM, and to examine the gland surface for a possible porous character in the cuticle and subjacent cell wall by LVSEM. Another objective is to prepare HPC-CS samples for additional immuno studies of substances in glands. Few or no such studies have been done on plant materials.